NPTX2: Preserving memory circuits in normative aging and Alzheimer's Disease

Abstract
The effect of aging on the human brain shows wide individual variation ranging from early onset Alzheimer's
disease (AD) to maintenance of cognitive clarity into the 10th decade. The challenge is to understand why
aging can have such disparate outcomes, and why it contributes so profoundly to the risk of neurodegenerative
disease. We have examined aging and AD from the perspective of molecular pathways that underlie memory
consolidation and determined that a gene termed NPTX2 provides an important clue to human cognitive
failure. NPTX2 is expressed by pyramidal neurons and secreted at their excitatory synapses on parvalbumin
interneurons (PV) to control inhibitory circuit function. NPTX2 and markers of PV function are prominently
down-regulated in the brain of humans with AD, and CSF levels of NPTX2 correlate with both disease state
and cognitive performance. NPTX2 is not down-regulated in the brains of individuals who maintain cognitive
clarity despite amyloid accumulation (asymptomatic AD). These and other findings support the hypothesis that
NPTX2 is associated with brain resilience critical for cognition and fails in the shift from healthy to unhealthy
aging. Aim 1 will identify signaling pathways associated with preserved or deteriorated NPTX2 expression
across the spectrum from older individuals with exceptional cognition to those with AD. Studies use an
approach of targeted proteomics combined with bulk and single nuclei RNAseq, and will specifically examine
the hypothesis that NPTX2 loss-of-function is associated with changes in interneuron cell properties. Aim 2
extends the goals of Aim 1 to establish the cellular mechanism of NPTX2 down-regulation using isogenic
human iPS neurons encoding familial mutations of APP and PS1. iPS neurons with fAD mutations show
profound and specific reductions of NPTX2 expression and provide an extraordinary opportunity to isolate and
validate critical disease pathways. Analyses will include TMT differential mass spectroscopy and RNAseq.
Candidate pathways will be manipulated and tested using CRISPR and pharmacological approaches. Aim 3
will provide the first test of the hypothesis that NPTX2 loss of function (LOF) in the adult brain is causal for
circuit dysfunction and cognitive decline in the context of AD pathogenesis. Experiments use a newly
established rat genetic model for conditional deletion of NPTX2 in a transgenic APP/PS1 AD model (Tg344-
AD). Analyses will include high density electrophysiological recordings in hippocampal subregions CA1 and
CA3 together with behavior tests and histopathological assessments of AD markers. Single nuclei RNAseq
performed in CA3 will define the signature of NPTX2 LOF in the context of amyloid pathology. These data will
be cross-referenced with findings from Aims 1 and 2 as part of an integrated interspecies analysis of the cause
and consequences of NPTX2 LOF. Combined studies will deepen our understanding mechanisms that can
confer cognitive health or bias the brain towards disease.

Public health relevance
Project Narrative This is a collaborative proposal to understand the molecular and cellular bases of memory changes in the context of aging and Alzheimer's disease. We have demonstrated that NPTX2, a marker of the information storage process, correlates with cognitive performance in humans during normative aging and in the context of Alzheimer's disease. Studies will examine the impact of NPTX2 reduction in human brain specimens and in neuronal circuits modeled in vitro using RNA and protein profiling, and the functional consequence of NPTX2 reduction on cognitive and behavior-linked circuit function using innovative rat models, and will provide fundamental new insights into memory, cognitive resilience, aging, and Alzheimer's disease.